MR/PET Motion Correction From Coil Fingerprints

PROJECT SUMMARY:
This proposal is devoted to the development, clinical implementation and evaluation of a novel, real-time,
motion correction methodology for concurrent MR/PET acquisitions. Available methods for data acquisition and
reconstruction in MR/PET scanners do not fully capitalize on the simultaneous imaging capabilities of the
commercially available MR/PET instrumentation. These capabilities could be used to obtain real-time
information for reducing motion artifacts and partial voluming bias from PET images without significantly
affecting the workflow of the corresponding MRI examination. Our methodology builds on the track record of
the multi-institutional research team with all aspects of MRI and PET data acquisition and reconstruction. The
proposed methodology will lead to improved sensitivity and quantitative accuracy for PET scans when they are
simultaneously acquired during the course of an MR/PET examination. Such improvements will lead to better
detection, staging and surveillance of small (<1cm) abdominal lesions, which assessment is currently limited
due to excessive signal loss from motion blur and partial voluming bias.

Public health relevance
PROJECT NARRATIVE: This project will develop new methodology designed to reduce motion-related errors when assessing small (<1cm) abdominal masses using concurrent Magnetic Resonance Imaging (MRI) and Positron Emission Tomography (PET) scans. The MR/PET scans generated with this methodology will lead to improved detection, characterization and monitoring of small abdominal lesions.